Mechanisms and therapeutic targets of cancer metastasis

Project Summary
Metastasis is the primary cause of morbidity and mortality in cancer with little improvement in outcomes over the
past decade. This is particularly evident in gastrointestinal cancers where metastasis to the liver is the most
common site of cancer cell spread. We hypothesize that the spread and growth of cancer cells in the liver is
dependent on formation of a reversible niche environment that is directed by hepatocytes, the chief functional
cells of the liver. In support of this hypothesis, we have found that primary tumors release soluble factors that
activate hepatocytes in the liver. This process begins during the earliest stages of cancer development. Activated
hepatocytes respond by releasing acute phase reactants which orchestrate a niche environment in the liver that
is underpinned by the recruitment of neutrophils and myeloid cells and the deposition of extracellular matrix
proteins. This environment supports cancer cell seeding and colonization. In the absence of this pro-metastatic
niche, disseminated cancer cells enter a state of cell dormancy in the liver. Although macrophages are a first-
line of defense against metastasis to the liver, their biology is also altered during formation of the niche
environment in the liver. Thus, our findings identify an intercellular network within the liver underpinned by
hepatocytes that responds to cancer development by preparing the “soil” that supports cancer cell “seeding”.
Our ultimate goal is to devise novel therapies that will resolve the pro-metastatic niche and redirect the liver
environment from pro- to anti-metastatic for treating and preventing cancer metastasis. However, this will require
an understanding of the signals by which hepatocytes direct formation of the niche and identification of strategies
capable of reversing the pro-metastatic potential of the niche. Therefore, in Aim 1, we will define the downstream
signals by which hepatocytes coordinate formation of a pro-metastatic niche in the liver. In Aim 2, we will identify
strategies to shift the niche environment in the liver from pro- to anti-metastatic. In Aim 3, we will investigate the
impact of hepatocytes on cancer cell dormancy in the liver and the efficacy of cytotoxic chemotherapy. Together,
these complementary aims will inform the development of therapies designed to condition the liver for anti-
metastatic potential as a strategy to prevent and treat cancer metastasis.

Public health relevance
Project Narrative Metastatic disease remains the primary cause of morbidity and mortality in cancer with little improvement in outcomes seen over the past decade. In this proposal, we investigate (i) mechanisms regulating the formation, (ii) the reversibility, and (iii) therapeutic implications of a niche environment in the liver that is supportive of cancer metastasis and growth. The proposed studies will incorporate clinically-relevant mouse models of cancer to inform development of novel strategies to prevent and treat cancer metastasis.